Characterizing genetic risk of cancer across diverse populations through multi-ancestry epigenome profiling and chromatin QTL discovery

PROJECT SUMMARY
Multi-ancestry genome-wide association studies (GWAS) are beginning to identify cancer risk loci that are
associated with genetic ancestry. Most GWAS risk loci affect regulatory DNA, and it remains challenging to
determine how genetic variants at these loci alter gene regulation to confer cancer risk. Chromatin QTLs
(cQTLs) are emerging as a powerful solution to this challenge. cQTLs are genetic variants whose genotype
correlates with the activity of a nearby regulatory element. cQTLs can pinpoint disease-causing genetic
variants and capture their effects on gene regulation, overcoming several shortcomings of traditional methods
for annotating risk loci. To date, cQTLs have been identified almost exclusively in populations of European
Ancestry (EA). Because of this, existing cQTL studies have not assessed hundreds of thousands of genetic
variants that are rare in EA populations but common in non-EA populations. Systematic efforts are critically
needed to identify cQTLs that account for cancer risk loci in ancestrally diverse populations. Our project will
test the central hypothesis that measuring gene regulation in ancestrally diverse cohorts will reveal novel
cQTLs that account for risk of common cancers. Aim 1 will identify cQTLs that confer risk of prostate cancer in
men of African ancestry by profiling regulatory element activity in a large panel of prostate cancers from Africa.
By targeting a profound racial diversity gap in existing cQTL studies, we expect to uncover thousands of novel
cQTLs, some of which contribute to the excess risk of prostate cancer in men of African Ancestry. Aim 2 will
leverage cQTLs to improve the accuracy of polygenic risk scores (PRS) for cancer in populations of diverse
ancestry. Our preliminary data suggest that this innovative approach should improve the poor performance of
cancer PRS in non-EA populations, overcoming a critical barrier to the equitable use of PRS. Aim 3 will identify
cancer-associated cQTLs from circulating chromatin in plasma samples from diverse US populations. This
novel approach will enable cQTL discovery at a speed and scale not previously achievable. It will thereby aid
the discovery of cancer-associated cQTLs in underrepresented populations. Completing these aims will
deepen our biological understanding of cancer-causing genetic variants that are common in non-EA
populations but poorly represented in current cQTL datasets. In turn, this will allow all people to benefit more
equitably from the biologic discovery and clinical applications emerging from cancer GWAS.

Public health relevance
PROJECT NARRATIVE This project will advance the National Cancer Plan’s goals of “engaging every person” and “eliminating inequalities” in genetic studies of common cancers. It will enable functional characterization of cancer-causing genetic variants that are common in populations of non-European Ancestry but poorly represented in existing chromatin QTL datasets. It will allow populations that have been underrepresented in genetic studies of cancer to benefit more equitably from the insights of cancer genome-wide association studies.